Experience-Dependent Reorganization of Excitatory Synapse Connectivity

Project Summary
Optimal refinement of neural circuits during development is a highly controlled process that depends critically on
experience. Ample genetic evidence in mental disorders points specifically to defects in molecular targets related
to experience-­dependent developmental plasticity of excitatory synapses, and dysregulation of this fundamental
developmental process results in a variety of neuropsychiatric diseases. This project seeks to elucidate
mechanisms by which experience sculpts the functional connection of excitatory synapses during development
and how perturbations in this process can derail the normal developmental trajectory. We found that during the
critical period of their functional maturation, excitatory synapses of the mouse primary visual cortex (V1) maintain
a dynamic equilibrium in their AMPA receptor-­mediated transmission. This equilibrium requires neurogranin (Ng),
a postsynaptic calmodulin-­binding protein important for synaptic plasticity, which is has been implicated in
schizophrenia and mental retardation. Our preliminary studies show that in addition to controlling incorporation
of AMPA receptors into AMPA receptor-­lacking (silent) synapses and synaptic pruning, Ng levels also control
the timing of the developmental switch in NMDA receptor subunits, and change the phosphorylation profiles of
several post synaptic proteins including NMDA receptor and PSD-­93/95. This project investigates the hypothesis
that Ng levels influence the experience-­dependent reorganization of excitatory synaptic connectivity by altering
Ca/CaM-­dependent signaling pathways, including PP2B and NMDA receptors, using a combination of virus-­
mediated gene manipulation, synaptic physiology, channel biophysics, morphological analysis, and behavioral
interrogation. The results will elucidate the molecular pathways governing experience-­dependent refinement of
excitatory synaptic connectivity during development and will help to identify potential targets for pharmacologic
interventions in patient with neurodevelopmental disorders.

Public health relevance
Narrative Experience- dependent refinement of excitatory synaptic connectivity is a fundamental developmental mechanism whose dysregulation leads to neuropsychiatric disorders. We found that neurogranin (Ng), a postsynaptic calmodulin (CaM)- binding protein and schizophrenia- associated gene target, regulates constructive synaptic refinement in visual cortex during the critical period. This study will use a combination of virus- mediated gene manipulation, electrophysiology, high- throughput and high- resolution channel biophysics, morphological analysis, and behavioral interrogation to better understand molecular mechanisms that control the organization of excitatory circuits during development, and thus help identify therapeutic approaches to address mental disorders.